Structure and Regulation of The Respiratory Syncytial Virus Polymerase

PROJECT ABSTRACT
The long-term goal of our project is to elucidate the molecular basis of the poorly understood mechanism of
the RNA synthesis machinery of NNS RNA viruses and to determine the structures of key protein complexes
involved in the RSV RNA synthesis, facilitating the development of antiviral drugs. Despite several decades of
research, the molecular mechanism of RNA synthesis by NNS RNA viruses remains elusive. The catalytic core
of the RNA synthesis machine of NNS RNA viruses is the RNA-dependent RNA polymerase (RdRP) that
comprises a large 250 kDa protein (L) and a cofactor phosphoprotein (P). The L protein catalyzes three
enzymatic activities: nucleotide polymerization, cap addition, and cap methylation. P is essential for the full
activity of L to act on the viral genome. In some cases, additional viral proteins (VP30 in Ebola and M2-1 in RSV)
are necessary for full RdRP processivity. Several important and long-standing questions for RNA synthesis
by NNS RNA viruses remain unanswered - First, how does L carry out the catalytic reactions of the
phosphodiester bond formation of the first two nucleotides (de novo RNA synthesis), RNA elongation (RNA
extension), and RNA polyadenylation (shutter mechanism)? Second, how does a single protein L coordinate
three distinct enzymatic activities (makes, caps, and methylates RNA), and what determines the switch to the
next process? Third, how do the cofactor P and transcription factor M2-1 regulate the activities of the L protein?
The lack of clear answers to these critical questions represents a major knowledge gap in our understanding
of the mechanism of NNS RNA synthesis. We propose to tackle these challenging questions with a novel hybrid
approach that integrates biochemistry, enzymology, mutagenesis, virology, genetics, crystallography, and cryo-
EM methods. Guided by our preliminary data, we hypothesize that the catalytic activities of RNA polymerization,
cap addition, and cap methylation reside within RSV L and that L requires a dynamic assembly with P and M2-
1 to coordinate these activities during RNA synthesis. To test this hypothesis, we will investigate the functional
interplay between the multi-functional enzyme L, cofactor P, and transcription factor M2-1. We will seek to
provide clear answers to the long-standing questions regarding the mechanisms governing RNA synthesis of
RSV and other NNS RNA viruses. The proposed research is significant and groundbreaking because the novel
knowledge and structures obtained from this proposed research will significantly advance our understanding of
RSV and NNS RNA synthesis. Ultimately, such knowledge will provide a framework for developing novel
antivirals to treat RSV infections.

Public health relevance
PROJECT NARRATIVE The proposed research has a strong public health need because the respiratory syncytial virus (RSV) is the top cause of lower respiratory tract infections among young children and older adults in the US and worldwide. RSV RNA synthesis machinery remains a high priority among non-segmented negative-sense (NNS) RNA viruses, and we seek to understand the molecular mechanism by elucidating the atomic details of the interaction surfaces and catalytic domains. The proposed research meets the NIH’s mission of reducing illness and disability caused by RSV and related NNS RNA viruses.